Mitochondrial Respiration and The Biology of Growth Plate Chondrocytes

Cell differentiation is a complex process in which bioenergetic metabolism, specifically glycolysis and oxidative
phosphorylation (OxPhos), plays a pivotal role. This role extends beyond ATP production and encompasses
factors like the accumulation of intermediate metabolites such as 2-hydroxyglutarate (2HG). In fetal growth
plates, hypertrophic chondrocytes are central to bone development. Despite their importance, our understanding
of their regulation by bioenergetic metabolism is still in its infancy. The fetal growth plate is a hypoxic and high
glycolytic structure. Hypoxia-inducible factor 1α (HIF1) is crucial for the survival of growth plate chondrocytes.
HIF1 promotes glycolysis and lactate fermentation while reducing OxPhos activity. The survival role of HIF1
relies on its partial inhibition of OxPhos. Recently, we generated a mutant mouse lacking Mitochondrial
Transcription Factor A (TFAM) in limb bud mesenchyme. TFAM, encoded by the nuclear genome, primarily
regulates the transcription of mitochondrial-encoded electron transport chain subunits. Loss of TFAM did not
impact the differentiation of mesenchymal progenitor cells into chondrocytes, chondrocyte proliferation, survival,
or physiological death. However, it significantly delayed chondrocyte hypertrophy, leading to shorter bones.
Thus, despite the high glycolytic activity of the fetal growth plate, its proper development still relies on OxPhos.
While TFAM is not a known nuclear transcription factor, single-cell RNA sequencing (scRNA seq) of mutant and
control growth plates at birth revealed significant changes in the expression of numerous genes involved in
chondrocyte biology. These changes included reduced expression of HIF1 target genes and increased
expression of genes involved in chondrocyte biology. Intriguingly, enhancing HIF1 activity appeared to slow
down endochondral bone development, suggesting that decreased HIF1 signaling does not mediate the delayed
hypertrophy observed in TFAM mutant growth plates. Untargeted metabolomics analysis revealed that levels of
intermediate metabolites like 2HG were significantly elevated in mutant cells. Additionally, exposing control cells
to hypoxia, thus activating the HIF1 signaling pathway, resulted in a similar increase in 2HG and other
intermediate metabolites. 2HG plays a role in controlling cell differentiation by modulating epigenetic events and
chromatin accessibility. Based on our preliminary data, we will test the following hypothesis: 1. loss of TFAM in
growth plate chondrocytes delays hypertrophy by suppressing OxPhos, resulting in elevated levels of
intermediate metabolites, such as 2HG, which modulate chromatin remodeling, ultimately affecting the nuclear
transcriptome; 2. Augmented HIF1 activity replicates the effects of TFAM loss by delaying chondrocyte
hypertrophy, reducing OxPhos activity, and increasing 2HG levels or other intermediate metabolites.

Public health relevance
NARRATIVE Understanding the role of mitochondrial respiration growth plate chondrocyte hypertrophy is still in its early stages. This proposal aims to fill this knowledge gap by investigating how mitochondrial respiration controls chondrocyte hypertrophy and, consequently, bone development. Understanding the relationship between mitochondrial respiration and chondrocyte hypertrophy may lead to novel therapeutic interventions for skeletal disorders.